Activity-dependent endocannabinoid control in epilepsy

Temporal lobe epilepsy (TLE) is the most common epilepsy syndrome in adults. Current treatment options
for TLE remain often inadequate, as many patients suffer from uncontrolled seizures and negative treatment
side effects. Endogenous cannabinoid signaling involving the cannabinoid type 1 receptor (CB1) is
recognized to be a major presynaptic regulator of inhibitory neurotransmitter GABA release throughout the
CNS. However, although the therapeutic potential of endo- and exogenous cannabinoids has been
recognized for various neurological and psychiatric disorders, the in vivo mechanisms of cannabinoid
signaling remain poorly understood, limiting the effective design of novel therapies. Major reasons for our
incomplete understanding of cannabinoid signaling in the intact brain include the highly unstable nature of
lipid-derived cannabinoid ligands and the prior lack of methods to study CB1-expressing neurons in behaving
animals. Recently, we have introduced new tools that overcome these challenges, finally offering
researchers both the ability to detect fast lipid signals in the hippocampus of behaving mice, and to
selectively monitor and manipulate CB1-expressing GABAergic cells in vivo. Here, we propose to employ
these new tools to test the hypothesis that activity-dependent endocannabinoid dynamics in the intact
hippocampus are persistently modified in chronic TLE. We will then leverage novel, non-invasive, closed-
loop interventions to target CB1-expressing GABAergic cells in order to control chronic seizures and
ameliorate TLE-related disturbances in spatial information processing. We will test our hypothesis in
experimental mouse models of chronic TLE, utilizing a variety of innovative in vivo calcium-imaging,
electrophysiology, optogenetic and behavioral approaches. We anticipate that our project will have
significant, potentially translatable, impact by overcoming major knowledge gaps about activity-dependent
cannabinoid signaling in normal and epileptic neuronal circuits in behaving animals, and by accelerating the
development of non-invasive closed-loop intervention strategies.

Public health relevance
Tens of millions of people in the world are burdened by epilepsy, and many of these patients have seizures that cannot be controlled with existing therapies. There has been a recent surge in interest in leveraging cannabis-related molecules to control treatment-resistant epilepsy. Our project will determine how the body’s own cannabinoids get generated and released following neuronal hyperactivity in the intact brain. We will then test how effectively cannabinoid-sensitive inhibitory neurons can be targeted for novel non-invasive therapies to control chronic spontaneous seizures.